Optimizing nucleoside analog efficacy with novel exonuclease inhibitors

Project Abstract
The world is currently under siege by the spread of a novel positive-strand RNA virus, severe acute respiratory
syndrome coronavirus 2 (SARS-CoV-2). All positive-strand RNA viruses require their virus-encoded RNA-
dependent RNA polymerase (RdRp) to synthesize RNA to serve as either mRNA for production of viral proteins
or as genomic RNA for progeny virions. Viral polymerases are well-established targets for antiviral therapy with
clear potential for broad-spectrum activity. The RdRp from hepatitis C virus (HCV), another positive-strand RNA
virus, is a key target of the antiviral cocktails developed to cure HCV infection. The most efficacious inhibitors of
viral polymerases with broad-spectrum activity are nucleoside or nucleotide analogs. This class of compounds
binds to the nucleotide substrate-binding pocket of the viral polymerase and is incorporated into nascent RNA,
leading to termination, mutagenesis, or recombination, all of which can be lethal to the virus. Given the conserved
structural and sequence requirements of the nucleotide substrate-binding pocket of viral RdRps, in general, it is
not at all surprising that a nucleotide analog developed to treat one virus would exhibit antiviral activity against
another. Potency in vitro and/or in vivo can differ. The problem in vivo often relates to failure of compound
activation and/or accumulation in the relevant tissue/organ. A coronavirus-specific complication for use of
nucleotide analogs is the presence of a 3’→5’ exoribonuclease activity capable of excising not only mismatched
basepairs but also some antiviral nucleotides. The primary motivation of this project, in alignment with the
Stanford AViDD Center (SyneRx), is development of safe, effective nucleoside/nucleotide candidates for use in
the treatment and/or prevention of SARS CoV-2 infection and perhaps other viral pathogens of the respiratory
system as well. A unique asset of our program is a panel of nucleotide analogs with activity against the SARS-
CoV-2 RdRp discovered by screening a library owned by Riboscience LLC. To increase the potency of these
candidates, we will antagonize excision by inhibiting the exoribonuclease. To achieve these goals we will pursue
the following specific aims: (1) Identify nucleotide analogs for development. (2) Develop strategies to antagonize
the exoribonuclease. (3) Synthesize and characterize ProTides and second-generation nucleotide analogs for
use as anti-coronavirus therapeutics. (4) Biological analysis of polymerase and exoribonuclease inhibitors.
Together, these studies have the potential to discover safe, efficacious nucleotide analogs for use in the
treatment of SARS-CoV-2 infection and perhaps other viral infections of the respiratory system.